Studies of Chemically Labile Alkylation Damage in DNA

ABSTRACT
Alkylation DNA damage caused by alkylating agents promotes mutations and cancer development. Guanine N7
is targeted by a wide range of alkylating mutagens, carcinogens, and anticancer agents, producing the cationic
N7-alkylguanine (N7-alkylG) adducts as major lesions. These lesions have half-lives of several hours to days in
DNA and thus can affect DNA replication and transcription. The positively charged N7-alkylG lesions can also
undergo further modification to generate secondary lesions such as alkyl-formamidopyrimidine (alkyl-FapyG)
adducts. The recognition, repair, and mutagenesis mechanisms of many mutagen/carcinogen-induced N7-
alkylG and alkyl-FapyG lesions, except for a few lesions such as N7-aflatoxin B1-G and aflatoxin B1-FapyG
adducts, remain poorly characterized, thereby precluding a complete understanding of the contribution of these
major lesions to mutations and cancer development. For example, the mutagenic properties of the predominant
N7-alkylG adducts produced by the cancer-promoting styrene oxide are unknown. This knowledge gap has
been due in part to the technical difficulty in preparing a site-specific N7-alkylG- and alkyl-FapyG-containing
DNA, which is ascribed to the rapid depurination of N7-alkylG nucleosides and the facile isomerization of alkyl-
FapyG during solid-phase DNA synthesis. To overcome the stability issue of N7-alkylG nucleosides, we have
developed a 2’-fluorine technology that prevents spontaneous depurination by increasing the stability of N7-
alkylG nucleosides. To solve the isomerization problem of alkyl-FapyG, we have taken a post-synthetic
approach that produces alkyl-FapyG-containing DNA from N7-alkylG-containing DNA. Our preliminary studies
show that guanine N7 alkylation can influence base-pairing properties by facilitating the formation of the rare
enol tautomer, syn base conformation, and/or intercalation. Our central hypothesis is that N7-alkylG and alkyl-
FapyG adducts promote mutations and cancer development by altering the base-pairing properties of the
damaged guanine. Our long-term research goal is to elucidate the biological impacts of chemically labile
alkylation damages and their secondary lesions using innovative approaches such as the 2’-F chemistry, the
polβ host-guest-complex system, and post-synthetic DNA modification. The objective is to dissect the biological
consequences of N7-alkylG and alkyl-FapyG lesions induced by potent alkylating mutagens and anticancer
agents such as nicotine-specific nitrosamine, styrene oxide, nitrogen mustards, and N-methylbenzyl nitrosamine.
To accomplish this objective, we will characterize the base-pairing properties and the recognition, mutagenesis,
and repair mechanisms of N7-alkylG and alkyl-FapyG adducts using combined tools of synthetic, biochemical,
structural biology, and cellular approaches. The successful execution of the proposed programs will greatly
advance our knowledge of the impact of carcinogen/drug-induced N7-alkylG and alkyl-FapyG lesions on the
base pair conformation, stability, tautomerism, mutagenesis, recognition, and repair, thereby providing important
insights into the alkylation damage-induced mutations and cancer development.

Public health relevance
PROJECT NARRATIVE The research proposed here is relevant to public health because it seeks to elucidate the biological ramifications of N7-alkylguanine and alkyl formamidopyrimidine lesions formed by various alkylating mutagens, carcinogens, and antitumor agents. Accomplishing our goal will greatly advance our understanding of the impact of these lesions on mutagenesis and cancer development.